Identifying drug synergistic with cancer immunotherapy

PROJECT SUMMARY
Avinash D Sahu, Ph.D., is a computational biologist whose overarching career goal is to solve longstanding problems in
cancer immunology and translational precision oncology using artificial intelligence (AI) and to devise new therapeutic
strategies for late-stage cancer patients. Entitled Identifying drug synergistic with cancer immunotherapy, the proposed
research combines cutting-edge AI technology with Immuno-oncology (IO) to produce a systematic approach to
identifying drugs that synergize with immunotherapy, and prioritize them for clinical trials for advanced melanoma,
bladder, kidney, and lung cancer.
Career development plan: Dr. Sahu is a recipient of the Michelson Prize, and his research mission is to initiate precision
immuno-oncology by moving patients away from palliative chemotherapy to more personalized IO treatments. His
previous training in AI, statistics, method development, cancer, and translation biology have prepared him to conduct the
proposed research. Dr. Sahu has outlined specific training activities to expand his skill set in four areas: 1) cancer
immunology, 2) AI, 3) translation research and 4) new immunological assays. This skill set will be necessary to gain
research independence. Mentors/Environment: Dr. Sahu mentoring and the advisory team assembles world-leading
experts in computational biology, translation and clinical research, AI, statistics, and immunology. Also, Dr. Sahu has
developed academic collaborations and industry partners to provide him experimental support for the proposal.
Leveraging the state-of-art software and google-cloud infrastructure provided by Cancer Immune Data Commons (CIDC);
computational resources from DFCI, Harvard, and Broad Institute; as well as unique access to largest immunotherapy
patient data from collaborators, Dr. Sahu is uniquely placed to identify most promising IO drug combinations.
Research: There is a lack of a principled approach to identify promising IO drug combinations that has often led to
arbitrarily designed IO clinical trials without a sound biological basis. The proposal formulates the first in silico predictor
to estimate drug’s immunomodulatory effect and potential to synergize with immunotherapies. Aim 1 builds a novel deep
learning predictor —DeepImmune— to predict immunotherapy response from transcriptomes. Aim 2 estimates the
immunomodulatory effects of drugs from for its drug-induced transcriptomic changes using DeepImmune. Aim 3
prioritize top predicted immunomodulatory drugs and validate their effect in pre-clinical models.
Outcomes/Impact: The successful completion of the proposal will result in a robust predictor to rationally combine
cancer therapies with immunotherapy and set the basis for a clinical trial to test the most promising combination therapy.
The career development award and mentored research will enable Dr. Sahu to become a leader in the new field of research
at the intersection of precision immuno-oncology and AI.

Public health relevance
PROJECT NARRATIVE Combining immunotherapies with other cancer drugs has emerged as a new hope for late-stage cancer patients, however, the lack of a principled approach to identify such effective combinations often led to poorly designed clinical trials. The proposed research engages state-of-art Artificial Intelligence techniques with drug-induced transcriptomic changes to identify drugs that synergize with immunotherapies and prioritize them for clinical trials. Its application, as well as the career development pursued by the investigator, will rationalize clinical trials, identify new treatments for advanced cancers, and advance precision immuno-oncology.